Integration of a Culturally Responsive Family Peer Delivered Engagement Strategy in Coordinated Specialty Care

ABSTRACT
Family member/support person engagement in mental health services has known benefits such as continuous
engagement, medication adherence, and improved quality of life among service users in the early stages of
psychosis. As such, early intervention services in the form of coordinated specialty care models include family
psychoeducation, an evidenced-based intervention. Despite the known benefit of family engagement less than
50% of family members engage in coordinated specialty care and even lower rates have been reported among
diverse families (e.g., ethnoracially minoritized, low socioeconomic), fueling disparities in service utilization. To
address this, we piloted and established the acceptability and feasibility of a family peer delivered FAMily
Engagement Strategy (FAMES), aimed at providing culturally responsive care to improve family member
engagement throughout coordinated specialty care and address disparities among historically underserved
communities (e.g., ethnoracial minorities, rural residents). Informed by the Health Equity Implementation
Framework, we propose to conduct a Hybrid Type 1 Effectiveness-Implementation designed trial, to examine
the effectiveness and evaluate the implementation of family peer delivered FAMES in eight coordinated specialty
care programs geographical distributed throughout the U.S. (New Mexico, Oregon, Tennessee, and
Washington). The aims of the proposal are to: 1) Conduct a fully powered stepped-wedge clustered randomized
trial with eight coordinated specialty care programs who will recruit 448 family member/support person and client
participant dyads to determine whether integrating FAMES improves engagement compared to attention control;
2) Examine mechanisms of change (self-efficacy, connectedness, motivation) and equity-related moderators
defined by key determinants (e.g., race, ethnicity, gender identity, individual and neighborhood socioeconomic
status, rural-urban) on treatment effects; and 3) Guided by RE-AIM, evaluate the implementation (reach,
adoption, implementation fidelity, and sustainability) of FAMES using a rigorous mixed methods approach that
includes 68 semi-structured interviews as part of a longitudinal qualitative component with family peers and CSC
team members. This project aligns with NIMH’s Strategic Plan and commitment to advancing equity in mental
health services.

Public health relevance
PROJECT NARRATIVE Family member/support person engagement in mental health services has been linked to reduced burden and stress and also has a profound impact on individuals in the early stages of psychosis (e.g., increased engagement, improved outcomes). The proposed project aims to address low family member/support person engagement and disparities in coordinated specialty care by using a culturally responsive family engagement strategy delivered by family peers to improve engagement. The goal of this project is highly relevant and aligns with NIMH Strategic Plan, in that it aims to increase reach of family education and support component of coordinated specialty care and address service utilization disparities.